Enrichment Program

PROJECT SUMMARY/ABSTRACT
Consistent with its overarching goal of fostering communication and collaboration among the large community
of nutrition and obesity researchers at Harvard, the Nutrition Obesity Research Center at Harvard (NORC-H)
Enrichment Program has the goals of (1) promoting collaboration and knowledge sharing among nutrition and
obesity researchers; (2) providing interactions between trainees at all levels to further education about nutrition
and obesity; (3) providing mentorship and resources for early career investigators, and (4) fostering diversity
among the nutrition/obesity research workforce. The program provides enrichment activities that bring together
accomplished researchers, clinical providers, junior faculty, and trainees from multiple disciplines to discuss
cutting-edge research and foster collaboration and mentorship. In addition, NORC-H gives a voice to the
importance of education in nutrition and obesity for trainees at all levels within the Harvard system and greater
Boston Community. One of the primary enrichment activities of the NORC-H is an Annual Symposium on an
emerging theme in nutrition or obesity research, with relevant lectures, panel discussions, and networking
opportunities to attendees from the Boston area and beyond. The Enrichment Program also supports trainees,
junior faculty, and researchers from backgrounds underrepresented in medicine (URM). Since the last grant
renewal, we have initiated a mentoring program for Pilot & Feasibility recipients, the NORC-H Diversity
Scholars program to support outstanding early career investigators from URM backgrounds, awards to
promote junior faculty and inclusive mentoring, office hours for key NORC-H leaders to increase their
accessibility to NORC-H members, and a NORC-H Associate Member Council for early-career NORC-H
members to network, collaborate, and take advantage of NORC-H resources. The Enrichment Program has
also continued to support multiple educational efforts by NORC-H members, including the Longwood Nutrition
Seminars and the Blackburn Obesity Course. Further, multiple members of the NORC-H are faculty on NIH
training grants, and NORC-H collaborates with these faculty to provide mentorship and support to trainees who
are the younger generation of investigators in the fields of nutrition and obesity. Finally, communication with
our Research Base and the larger community is a key function of the Enrichment Program, serving to increase
cohesiveness and collaboration and to help researchers and providers stay current on the most recent
scientific advances in the field. To accomplish this, the Enrichment Program maintains the NORC-H website,
with information about NORC-H Cores, resources, links to NORC-H publications, The NORC-H disseminates a
bi-monthly newsletter to over 900 subscribers with announcements, featured publications, early career
investigator profiles, and local events related to nutrition and obesity. Through these activities, the Enrichment
Program strengthens our community through education, networking, collaboration, and mentorship.